Contribution of Thirdhand Smoke to Overall Tobacco Smoke Exposure in Pediatric Patients

Project Summary
Thirdhand smoke (THS) is the persistent residue resulting from secondhand smoke (SHS) that accumulates in
dust, in objects, and on surfaces in homes where tobacco has been used. Smokers' homes become reservoirs
of persistent toxic pollutants (e.g., nicotine, polycyclic aromatic hydrocarbons (PAH) and tobacco-specific
nitrosamines (TSNA)). Some THS pollutants continue to undergo further chemical changes in the home (e.g.,
nicotine to TSNAs). Children are exposed to THS toxicants via inhalation, dermal transfer, and ingestion of
compounds from indoor reservoirs, and we recently demonstrated that children of smokers carry THS
pollutants on their hands. Children are up to 100 times more sensitive to dust pollutants than adults. Even in
homes with smoking bans, children have 5-7 times more nicotine exposure than children in nonsmoking
homes. Nicotine and TSNA exposure from THS can be 6.8 and 16 times higher in toddlers, respectively, than
what would be inhaled through SHS, and there is concern that THS causes hazardous health effects in
children. Very little is known about the extent to which THS contributes to children's overall levels of tobacco
smoke exposure (OTS), defined as their combined THS and SHS exposure. Even less is known about the
effect of OTS and THS on child health. Building on prior research and leveraging the experimental design from
an active tobacco cessation trial of caregivers who smoke and their children (R01HD083354), we propose the
first project to examine how different home smoking behaviors contribute to THS and OTS. Our hypothesis is
that independent of SHS, THS contributes significantly to OTS such that higher levels of THS pollutants in the
home are associated with higher levels of THS exposure in children and that THS persists even after smokers
quit. Further, we hypothesize that higher levels of THS exposure are associated with respiratory-related
diagnoses, interventions, and positive test results. We will test these hypotheses within three aims using hand
wipe, urine, air, and dust samples and medical record review of children before and 6-weeks and 6-months
after a cessation intervention. Biological and environmental samples will become part of a unique repository for
future research. Our aims are: 1) To examine the contribution of THS in children's environments to their OTS
exposure; 2) To determine the levels and composition of THS pollutants in house dust in smokers' homes 6-
months after a cessation intervention; and 3) To examine factors associated with THS and OTS levels and to
explore if these levels are associated with increased rates of respiratory illness (e.g., asthma). If our
hypotheses are supported, our findings will be crucial to help close gaps in our understanding of the types,
quantity, and clinical effects of OTS, THS exposure, and THS pollutants in a unique sample of smoke exposed
ill children and their homes. The potential impact of these findings is substantial, as currently the level of risk
attributable to THS is unknown. This research has the potential to change how we protect children from OTS,
by recognizing that SHS and THS needs to be addressed separately as sources of pollution and exposure.

Public health relevance
Public Health Relevance The goal of this project is to better understand the unique contribution of thirdhand smoke and secondhand smoke to children’s overall tobacco smoke exposure and to identify the levels and composition of thirdhand smoke pollutants in children’s home environments. Using this information, we will be able to determine the types and levels of thirdhand smoke pollutants that persist in an environment where secondhand smoke has been eliminated as a pollution and exposure source. We will identify additional strategies to protect children from thirdhand smoke exposure through indoor reservoirs that persist after secondhand smoke exposure has been eliminated.